Frequent Standardized Oral Care Using Human Milk to Reduce Gastrointestinal Dysbiosis and Inflammation to Improve Health Outcomes and Reduce Cost in Preterm Very Low Birth Weight Infants

Project Summary/Abstract
In critically ill adults, evidence based guidelines for oral care are well established and known to reduce
complications.1 However, in preterm infants admitted to the neonatal intensive care unit (NICU), no such
guidelines exist and there is a dearth of information regarding oral care for preterm VLBW (< 1500 grams at
birth) infants who because of their suppressed immunity and physiologic immaturity, are at increased risk of
morbidity due to infrequent and non-standardized oral care.2 The optimal frequency and element to use for oral
care to decrease oral/intestinal inflammation and microbial dysbiosis and to decrease cost of care is unknown.
The overall objective of this 3-year study is to determine whether frequent standardized oral care using human
milk reduces oral/intestinal inflammation and microbial dysbiosis (decreased beneficial bacteria; increased
potentially pathogenic bacteria; decreased alpha diversity) leading to improved neonatal outcomes thus
reducing cost of care. Previously collected oral and stool samples will be analyzed for inflammatory markers,
metagenomic composition, and the cost and cost effectiveness of the intervention will be determined. The
proposed study is a secondary analysis of data from an ongoing prospective randomized controlled trial of 168
racially diverse male and female preterm VLBW infants. Infants are randomized into 1 of 3 groups. Oral care is
provided every 3-4 hours using human milk (Group 1); every 3-4 hours using sterile water (Group 2); and every
12 hours using sterile water (Group 3: standard care) for 4 weeks after birth. Aim 1 will evaluate the effect of
frequent standardized oral care using human milk on oral inflammation in preterm VLBW infants. For Aim 2,
we will characterize the metagenomic composition of oral and stool samples and their impact on inflammatory
profiles. Aim 3 will determine the cost and cost effectiveness of frequent oral care using human milk. Results
are expected to fill an important gap in research regarding frequent standardized oral care using human milk
and whether it decreases oral/intestinal inflammation and dysbiosis and reduces cost of care.

Public health relevance
Narrative The goal of this study is to improve short and long-term health outcomes for premature very low birth weight (VLBW) (<1500 grams) infants by decreasing oral/intestinal inflammation and microbial dysbiosis caused by lack of frequent standardized oral care using human milk. Results are expected to: (a) fill an important knowledge gap regarding the optimal frequency and element to use for oral care, (b) influence protocols and practices regarding oral care, and (c) significantly decrease the costs related to complications and lengthy hospital stays for this vulnerable population of premature infants.